Using a SMART design to evaluate remotely delivered, culturally tailored weight loss interventions among Latina breast cancer survivors

PROJECT SUMMARY / ABSTRACT
Breast cancer (BC) is the leading cause of cancer death among US Latinas. Latinas are at high risk of obesity
and obesity-related diseases, which are associated with poorer cancer outcomes. There is a significant lack of
an effective intervention to address the diverse needs of Latina BC survivors to achieve a healthy weight. We
have developed and tested multi-component weight loss, dietary change, and physical activity (PA)
interventions among BC survivors, with a focus on experiential learning (EL) among Latinas. As the next step,
we propose a sequential multiple assignment randomized trial (SMART) testing 12 month adaptive culturally-
tailored weight loss interventions in a geographically diverse group of Latina BC survivors. The adaptive
interventions will use the CDC’s Diabetes Prevention Program (DPP), an evidence-based weight loss program,
as the central educational component. Based on our prior work, we will adapt the DPP to be remotely
delivered, include information specific to BC survivors, and be culturally-tailored to Latinas. Women will be
recruited via 3 West Coast SEER registries. Inclusion criteria: Diagnosis of stage I-III BC within 5 years, no
evidence of recurrent disease, >60 days post-treatment, and body mass index (BMI) 30 kg/m2. Baseline, 1, 3,
6, and 12 month assessments will include questionnaires on medical history, diet, and patient-reported
psychosocial/quality of life outcomes; objectively measured weight; accelerometer measured PA; and dried
blood spots to measure inflammatory/cardiometabolic biomarkers. Qualitative interviews with a subset of
participants will take place at 1 and 12 months. The goal of the 12 month ¡Vida! (Life!) program is to achieve
7% weight loss. Following baseline assessments, participants (n=410) will be randomized to ¡Vida! or ¡Vida! +
EL. At 1 month, responders (2% weight loss) will continue with their intervention and non-responders (<2%
weight loss) will be re-randomized to receive augmented behavioral support (i.e., combinations of EL,
individualized health coaching, and delivered groceries). Aim 1) To compare the effectiveness of four adaptive
interventions for weight loss in Latina BC survivors, beginning with ¡Vida! or ¡Vida! + EL (Stage 1) followed by
augmented behavioral support for 11 months for non-responders (Stage 2). Aim 2) To use a novel data-driven
approach to determine whether key individual baseline characteristics moderate the effect of the adaptive
interventions on weight loss, and thus lay the groundwork for more personalized adaptive weight loss
strategies. Exploratory Aims will i) assess whether intervention engagement moderates the effect of the
adaptive interventions on weight loss; ii) compare the effects of adaptive interventions on changes in
inflammatory and cardiometabolic biomarkers, diet quality, and PA; iii) quantitatively assess biopsychosocial
predictors/mediators of behavior change; and iv) qualitatively assess the participant experience to understand
factors that contribute to study outcomes. The trial will generate evidence on the best strategies for an
effective, scalable weight loss program to promote healthy cancer survivorship among Latina BC survivors.

Public health relevance
PROJECT NARRATIVE Cancer is the leading cause of death among Latinos, and among Latinas, breast cancer is the leading cause of cancer death. Latinas are a population at high risk of obesity, diabetes, and other cardiometabolic comorbidities, which are associated with poorer breast cancer outcomes. We will test adaptive interventions to identify the most effective multi-component home-based, online, culturally-tailored weight loss adaptive intervention in Latina breast cancer survivors.